Targeted Prevention for Non-Melanoma Skin Cancer

ABSTRACT
Overall Targeted Prevention of Non-Melanoma Skin Cancer
Skin cancer is the most common malignancy worldwide. One out of three new cancers is a skin cancer.
Approximately 5 million cases of non-melanoma skin cancer (NMSC) – basal cell carcinoma (BCC) and
cutaneous squamous cell carcinomas (cSCC) occur annually. Incidence rates for NMSC continue to rise,
creating a substantial impact on morbidity and health care costs that account for $8.1 billion/year for skin cancer
treatment. The majority of these lesions represent keratinocytic neoplasms. The overall goal of this multi-
institutional Program Project Grant (PPG) is to employ novel technologies and develop new targeted prevention
strategies to eradicate intraepithelial neoplasias in the skin (e.g. actinic keratosis, squamous cell carcinoma in
situ), and thereby, to dramatically reduce the risk of cSCC. To achieve this goal, we will conduct a multilevel
program of rational drug development, including: 1) to assess, in experimental models and human studies, the
significance of TLR4 and TOPK/PRPK signaling pathways in skin carcinogenesis leading to cSCC development;
2) to evaluate the relationship between TLR4 and TOPK/PRPK activation and previously established signaling
pathways of relevance in AK and cSCC development; 3) to identify and develop novel therapeutic preventive
agents that specifically “hit” these molecular targets in cSCC mouse models and effectively modulate their
signaling pathways; 4) to test the most promising target-specific agents in preclinical pharmacology models; and
5) to assess target engagement and safety of selected agents through pilot and Phase 1 clinical trials.
Knowledge of the key molecular targets in solar ultraviolet (UV) radiation signaling pathways and the
development of multiple topically administered agents that can hit and effectively modulate these targets
ultimately will allow for precision medicine based approaches in cSCC prevention. While the two basic science
projects (Projects 1 and 2) aim to identify and validate UV-induced signaling pathways and agents that modulate
these targets, the clinical project (Project 3) will undertake the task of moving leading candidate drugs from
mouse models into acute solar simulated light studies and Phase 1 clinical trials. Novel technologies include
signaling network analysis using state-of-the-art proteomic arrays and whole transcriptome analysis coupled with
the latest exploratory and downstream bioinformatic approaches and in vivo reflectance confocal microscopy for
non-invasive assessment and selection of tissue samples in human skin. This highly integrated and translational
research based program project, emphasizing a multidisciplinary, precision medicine approach for the prevention
of cSCC of the skin can also serve as a model for preventing other epithelial malignancies.

Public health relevance
PROJECT NARRATIVE [NO CHANGE] Overall Targeted Prevention of Non-Melanoma Skin Cancer The overall goal of the Targeted Prevention for Non-Melanoma Skin Cancer P01 is to employ novel technologies and develop molecularly targeted chemopreventive strategies to dramatically reduce the risk of squamous cell carcinoma of the skin (cSCC). Reducing the incidence of cSCC skin cancers and actinic keratoses (AKs) would not only reduce their potentially severe morbidity and mortality, but also dramatically reduce the multibillion dollar health bill associated with surgical and medical treatments required for non-melanoma skin cancers and AKs.